Genetic and genomic approaches to better understand the clinical heterogeneity in inflammatory bowel diseases

The inflammatory bowel diseases (IBD), Crohn's disease (CD) and ulcerative colitis (UC), are significant causes of morbidity with recent estimates suggesting there are more than 3 million Americans with IBD with very significant financial burden to the US economy. More than 200 genetic loci that increase susceptibility to IBD have been identified with the anticipation that an understanding of the molecular architecture of IBD will lead to improved outcomes for patients. However, there are significant challenges remaining to achieve this and this proposal seeks to address some of these key issues. 1) The majority of advances have been made in European ancestry populations and we aim to continue our efforts to recruit and study non European populations to extend the benefits of these advances to all parts of society. 2) We will address unmet medical needs by focusing on genetic discovery in two areas: peri anal fistulizing CD is associated with poor quality of life, significant morbidity, and poor response to treatment; and non response to anti TNF therapy which happens in the majority of subjects with IBD. This latter phenotype is increasingly important to define as new therapeutic options become available for treating IBD. 3) Many of the IBD associated loci fall in intergenic ('junk' DNA) regions and their functional consequences remain unclear. Using innovative genomic approaches together with state of the art bioinformatics strategies we propose to identify the processes that are influenced by the susceptibility loci we have identified. 4) And finally we will extend our previous observations that Paneth cell phenotypes are an important readout of gene environment interactions, as well as an important clinical biomarker, in CD to populations from a variety of ethnicities and geographical locations. Collectively, these approaches will shed additional insights into the underlying causes of IBD as well as identify additional biomarkers for use in clinical practice and highlight novel potential therapeutic pathways for IBD.

Public health relevance
The inflammatory bowel diseases are increasingly common conditions with a peak onset during early adult life that are associated with a poor quality of life and are a considerable financial burden to society. In this proposal we aim to identify the genes that predispose to severe forms of this disease that are resistant to current therapies. We also aim to use `cutting edge' genomic technologies and bioinformatics to determine the functional consequences of these genetic variants. Finally, we will examine pathology features from samples taken from patients from different ethnicities and different regions in order to determine the genetic and environmental contributions to a severe form of Crohn's disease. Through these studies we hope to develop areas for research for developing new treatments for these diseases.